Functions of the rete ovarii in ovary development, adult homeostasis, and female reproductive longevity

Abstract
There is an urgent need to understand the factors determining female reproductive longevity.
Female reproductive aging is characterized by a significant decline in reproductive function due to the
sequential decrease in the number and quality of ovarian follicles that constitute the finite ovarian reserve. The
rete ovarii (RO) is a conserved epithelial structure divided into 3 regions, the intraovarian rete (IOR), located
within the ovary, the extraovarian rete (EOR), located in the periovarian tissue, and the connecting rete (CR),
which links the EOR and IOR. The RO has been depicted for decades in anatomical context, and is a possible
contributor to gynecological disease, yet its function has never been thoroughly investigated. The reproductive
longevity of females is determined by three main factors: 1) the size of the initial primordial follicle pool, 2) the
rate of ovulation and atresia during the fertile window, and 3) perturbations, such as changes in metabolic
status or hormone levels, which affect ovarian function and follicle growth. The objective of this application is
to elucidate the contribution of the RO to each of these determining factors. To allow visualization and
functional investigation of the ovary in situ, I developed tissue clearing and 3D imaging methods that suggest
a role for the rete in the assembly of ovarian cells into ovigorous cords and subsequent specification of
medullary and cortical domains. I found that the RO remains closely associated with the ovary throughout
adulthood, and preliminary ovary transplantation experiments suggest that the host EOR/CR reestablishes a
connection to the IOR of the grafted ovary. Our transcriptomic data of the RO shows enrichment of secretory
and metabolic pathways consistent with the finding that Dextran injected into the EOR is transported to the
ovary. These data have led to the central hypothesis that the RO plays critical roles in the establishment
of the ovarian reserve and in the regulation of ovarian follicle growth in response to physiological cues.
This hypothesis will be tested by pursuing three specific aims: (1) (K99) Characterize the contribution of the
RO to the development of the ovary and the establishment of the ovarian reserve; (2) (K99/R00) Define the
functional differences between EOR and IOR in adult homeostasis and (3) (R00) Investigate the changes of
the RO in response to physiological cues. Discovering a role for the rete ovarii in the establishment of the
ovarian reserve and in the regulation of adult follicle growth under homeostatic or perturbed conditions
will situate the RO as a new candidate in the search for determinants of female fertility and reproductive
longevity. In addition, the approaches I develop will be useful in future investigations of interactions
between the ovary and other extrinsic tissues. Pursuit of these aims requires training in single-cell RNA
sequencing, mouse surgery and virally-mediated approaches for manipulating gene expression. I have
assembled an advisory committee chaired by Dr. Capel, and we designed a training plan that will provide me
with the skills required to run a productive, independent developmental and reproductive biology laboratory.

Public health relevance
Project Narrative The rete ovarii is a conserved epithelial structure that develops in parallel with the ovary during fetal life and remains closely associated with the adult ovary. This research will elucidate the precise nature and functions of the rete ovarii and its contribution to female reproductive longevity. This project will establish an integrated approach, all the way from 3D images to molecular signatures at the single cell level, which will enhance our understanding of the nature and importance of interactions between the ovary and extrinsic associated tissues, including the rete ovarii, for ovarian functions and fertility.